Identification of small molecule inhibitors of Pseudomonas aeruginosa lipoxygease (pLOXA)-induced ferroptosis

The bacterial pathogen - Pseudomonas aeruginosa - can oxygenate arachidonic acidphosphatidylethanolamines (AA-PE) in host cells and induce theft-ferroptosis by hijacking the mammalian polyunsaturated fatty acid PUFA-PE and death program. As such, lipoxygenase (pLoxA) may represent a new therapeutic target against this bacterial threat.

During this period, the project team worked to optimize a primary screening assay capable of identifying inhibition of Pseudomonas aeruginosa lipoxygease (pLOXA)-induced ferroptosis.